Hedgehog Signaling as a regulator of progenitor differentiation for organ maintenance and disease

PROJECT SUMMARY
The Hedgehog (Hh) singling pathway orchestrates organ development, but its precise timing
remains unclear. This project investigates whether Hh acts as a "heterochronic switch," controlling
differentiation timing across organs. We aim to decipher the heterochronic switch role of Hh
singling in lung development and potential contribution to two major lung diseases (COPD and
IPF). Using a robust computational pipeline, we will analyze existing single-cell data from mouse
and human lungs with three specific aims: 1) Deciphering Hh's temporal control: We'll analyze
existing mouse datasets to understand how altered Hh impacts differentiation in both loss-of-
function and gain-of-function scenarios. 2) Unveiling human lung dynamics: We will classify,
track, and characterize Hh-receiving cells across fetal and adult lungs, comparing them to reveal
changes in Hh timing control during development. And 3) Connecting Hh to disease: We will
assess the impact of altered Hh signaling on lineage-specific cell populations in COPD and IPF,
identifying disease-specific Hh target genes for further investigation. This proposed computational
work could assess whether and how Hh acts as a differentiation timing control on lung progenitors,
in normal development and disease. The impacts of this project include: (1) the first quantification
of Hh's role in regulating lung differentiation timing; (2) a set of disease- and lineage-specific Hh
target genes, potentially leading to new therapeutic strategies, and (3) a validated pipeline for
studying heterochronic control in other organs. Therefore, success of this project can enhance
our understanding of organ regeneration and disease pathogenesis. Beyond lung diseases, this
project could potentially illuminate Hh's heterochronic role in various organs and diseases, paving
the way for novel diagnostic and therapeutic approaches.

Public health relevance
Understanding fundamental knowledge about cell signaling pathways can lead to new treatments in the long term. This research investigates a key signaling pathway that controls how lung cells mature. By studying how this pathway goes wrong in major diseases like chronic obstructive pulmonary disease (COPD) and idiopathic pulmonary fibrosis (IPF), we hope to discover new ways to help lungs heal and prevent these debilitating conditions.